Impact of TNF on Oncolytic Virotherapy

Project Summary: Oncolytic virotherapy (OV) represents a novel method to treat a variety of solid tumors by
inducing anti-tumor immune responses. While this therapy has been extremely efficacious in a wide variety of
preclinical models, translating these successes into human patients has proven challenging. It has recently
become clear that one of the major reasons for these failures is the existence of immune-regulatory
mechanisms which dampen the efficacy of virally induced anti-tumor immunity. However, the exact nature of
these regulatory pathways remains unclear.
Our lab has previously developed a novel oncolytic MYXV which expresses a soluble PD1 inhibitor and an
IL12 fusion protein (vPD1/IL12). This construct is highly effective at treating disseminated disease, however,
~50% of tumor models remain at least partially non-responsive and viral treatment is associated with the
development of immune-related adverse events. In our follow-up studies into the mechanisms mediating the
efficacy of vPD1/IL12 we have observed that the virus induces high levels of TNF during therapy. Strikingly,
both genetic elimination or antibody-based blockade of this TNF results in a significant INCREASE in
therapeutic efficacy as well as a significant REDUCTION in toxicity. To our knowledge, no other studies have
demonstrated a positive impact of TNF blockade on OV and therefore both the mechanism(s) involved as well
as how to leverage this finding into improved clinical outcomes remains unclear. We therefore put forth the
current proposal which contains three specific aims designed to build off of our exciting preliminary data by:
identifying the mechanism through which TNF restricts OV efficacy, understanding how TNF mediates OV-
induced toxicities, and determining clinically applicable methods to apply TNF-blockade during OV. This work
will advance not only the clinical use of our existing vPD1/IL12 virus, but also improve our understanding of the
basic mechanisms involved in successful OV.

Public health relevance
Project Narrative: The anti-tumor immunity induced by oncolytic virotherapy is blunted by numerous poorly characterized cellular pathways. For example, our preliminary data demonstrates the presence of TNF within the tumor microenvironment prevents effective oncolytic therapy by directly killing anti-tumor T cells. The current proposal will more fully examine the impact of TNF on oncolytic therapy by understanding the molecular mechanisms involved and identifying how to best translate these findings into human patients.